GENETIC EVENTS IN MULTISTEP CARCINOGENESIS OF MICE

Our goal is to define mechanisms by which tumor suppressor genes are inactivated during chemical carcinogenesis in mice and humans. DNAs from butadiene-induced lung and mammary carcinomas and lymphomas, as well as methylene chloride-induced lung tumors, of B6C3Fl mice from the National Toxicology Program were examined for losses of heterozygosity. Southern analysis of endogenous virus loci identified deletions in several chromosomal regions and demonstrated that nonspecific allelic losses were rare. Six loci on chromosome 4 were analyzed using length polymorphisms in restriction fragments and microsatellites. The Ifa-2 locus was lost most frequently; 80% of lung tumors and 30% of lymphomas exhibited allelic losses. A tumor suppressor gene was previously mapped to this chromosomal region in somatic cell hybrid studies and homozygous deletions have been reported in a homologous region of human chromosome 9p for a variety of cancers, including lung. Likewise, use of an RFLP within the retinoblastoma gene (chromosome 14) demonstrated loss of one allele in half of the mammary tumors. Five chromosome 11 markers around the p53 gene were lost in 80% of mammary tumors, 30% of lymphomas, and 25% of lung tumors. p53 mutations were identified in a subset of these tumors by Southern and Western blotting as well as by analysis of single strand conformation polymorphisms and direct sequencing of PCR products. Finally, analogous tumors are being generated in a panel of transgenic mouse lines for comparison with genetic alterations observed in chemically induced tumors. To date we have shown by Western analysis that p53 alterations occur specifically in mammary tumors induced by the MMTV-myc transgene.